UTHealth/MDACC MSTP Alumni Mentoring Program

PROJECT SUMMARY Alumni of academic programs are among the best mentors for trainees as they provide trainees a direct lineage of success, and mentors are motivated by a sense of allegiance to the program and its trainees. We propose the creation of a network of alumni mentors to support and advise our MSTP students during the final years in the MSTP and into the most vulnerable periods of their post graduate careers, from residency to independent investigator. Beginning with facilitated interactions and alumni mentor training, a framework for recurring virtual and in-person meetings and parameters for accountability will be established as we initiate this program. The goal of this project is to increase the number of graduates pursuing research as a major component of their future careers.

Public health relevance
PROJECT NARRATIVE This project aims to establish long-term mentorship of our Medical Scientist Training Program (MD/PhD) graduates by a network of successful senior physician-scientist alumni of our program, with the goal of increasing the number of graduates pursuing research as a major component of their future careers.